Mechanisms of ubiquitin signaling in chromatin-mediated processes Diversity Supplement

PROJECT ABSTRACT
The mechanism by which eukaryotic genes are activated is inextricably linked with the packaging of DNA into
chromatin. Coactivator complexes with histone-modifying activities play essential roles in this process by
altering chromatin dynamics and interactions. Although there have been major advances in a molecular
understanding many of the key macromolecular machines involved in eukaryotic transcription, progress in
understanding coactivator function has lagged due to limited structural information on these large complexes
and their interactions with chromatin. This project has focused on understanding the regulation of eukaryotic
transcription and the connection between histone modifications and gene activation. A major focus has been
on the role of histone ubiquitination in regulating transcription, and on the mechanism of cross-talk between
histone ubiquitination, methylation and acetylation. Two major tools in our approach are cryo-electron
microscopy (cryo-EM) and the development of a large array of designer chromatin templates, which have been
instrumental in our ability to capture multisubunit complexes bound to modified chromatin templates. Since the
start of this award we have made substantial progress in our structural and biochemical studies of enzyme
complexes that mediate cross-talk between histone H2B ubiquitination and histone H3 methylation and have
identified novel inhibitors of the SAGA complex’s histone H2B deubiquitinating module. Our ongoing studies
are addressing the mechanism governing specificity of ubiquitin conjugating enzymes for histone H2B-K120,
the role of this ubiquitin mark in regulating access to chromatin, and role of histone code cross-talk in
regulating histone methyltransferases and demethylases. Many of the complexes we study, including MLL-1,
Dot1L complexes, and the USP22/SAGA DUB module play a central role in a variety of cancers. Our
mechanistic studies and drug discovery efforts are thus providing a foundation for developing novel
therapeutics that target these chromatin-modifying enzymes.

Public health relevance
PROJECT NARRATIVE Many tumor types are characterized by altered patterns chemical tags found on the histone proteins that package the human genome, leading to defects in gene regulation and DNA repair. Insights into the molecular mechanism by cells attach and remove these tags, as well as how the tags regulate gene expression and DNA repair, can be used to devise new therapies. This research will aid efforts to develop drugs to treat cancers that are resistant to current drugs.